PRECISION ASSESSMENT OF DXA

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this study is to assess the precision (similar measurements will be obtained when someone is scanned twice during the same visit) of bone mineral density and total body fat percentage of the DXA technicians utilized in GCRC-supported studies.